The novel role of meningeal macrophages in amyloid plaque deposition

Accumulation of β-amyloid (Aβ) in the form of brain plaques is a hallmark of Alzheimer's disease (AD). Multiple studies in humans as well as mouse AD models have shown dystrophic neurites inside and surrounding Aβ plaques, and shown a slew of neuronal deficits correlated with Aβ deposition that likely contribute to memory loss and cognitive decline seen in AD. Aβ accumulation could be the result of excessive production or defective clearance of Aβ, or a combination of both. Many studies have focused on the production of pathogenic forms of Aβ, in particular Aβ42. Much less is known about the clearance process of Aβ from the brain. A strong indication that defective Aβ clearance is involved in the pathogenesis of AD comes from studies showing that the concentration of Aβ42 in the cerebrospinal fluid (CSF) is lower in AD patients relative to controls very early in the disease process. In preliminary studies, we have observed a rapid and efficient uptake of dextran rhodamine and Aβ42 by meningeal macrophages. By specifically ablating meningeal macrophages in the brain, we will test the hypothesis that meningeal macrophages are important in the clearance of Aβ and therefore their absence contributes to an incrased AD plaque size. We further hypothesize that meningeal macrophages do not work as effectively in AD as in healthy undividuals, as measured by number and/or phagocytic capacity and/or activation state. The proposed studies will elucidate important functions of meningeal macrophages in regulating amyloid clearance and deposition in the pathogenesis of AD.

Public health relevance
The brain has a variety of mechanisms to effect the clearance of catabolites and toxic molecules, such as the ones that cause the formation of plaques in Alzheimer’s disease. We will focus on a type of brain macrophage present in the meninges. These meningeal macrophages are normally adept at taking up toxic compounds and catabolites; we postulate that ablation of this clearance system could lead to accelerated onset of Alzheimer’s disease, or a more severe disease with larger amyloid plaques.